Data Management and Analysis Core

PROJECT SUMMARY / ABSTRACT (Data Management and Analysis Core)
The Data Management and Analysis (DMA) Core will provide comprehensive data science support for the
Program Project Grant (PPG): Precision Cardiovascular Disease Phenotyping and Pathophysiological
Pathways in the CARRS cohort (Precision-CARRS). The overarching goal of the DMA Core is to maintain
high scientific rigor in the management and analysis of large and complex datasets. The DMA Core will be
based at Emory University and the Center for Chronic Disease Control (CCDC) in India. The DMA Core will
include 8 investigators with comprehensive data science expertise and a dedicated team of database engineer,
data managers and biostatisticians from both the US and India. The DMA Core will oversee data
management, data sharing, and the development of common analytic frameworks to promote integration and
synergy across the interconnected aims of the Precision-CARRS Projects. The DMA Core will work closely
with the Administrative and Field Coordination (AFC) Core and the CVD Phenotyping Core to ensure high
quality data capture and documentation, as well as to provide continuous infrastructure and management for
all research data from Precision-CARRS (Aim 1). By leveraging and expanding existing data platforms, we will
establish workflows and protocols for consistent data cleaning, harmonization, monitoring and documentation
for diverse datasets, including longitudinal surveys, subclinical and clinical phtenotypes, blood and urine
biomarker measurements, environmental exposures, and data from high-throughput omics technologies and
digital sensors. The DMA Core will also work closely with all Reseach Projects to provide centralized support
for data analysis using state-of-the-art biostatistics, bioinformatics and maching learning methods (Aim 2).
Specifically, the DMA Core will create synchronized analytic plans for both epidemiologic modeling and
predictive equation development across projects. To provide integrated and timely data science support
throughout the PPG, two DMA Core investigators (one from Emory and one from CCDC) will serve as liaisons
for each Core and Project. Finally, the DMA core will support the development of new and innovative analytic
methods motivated by the scientific goals of Precision-CARRS (Aim 3). The DMA Core is particularly poised to
contribute in the areas of machine learning for predictive health, latent variable models for handling multivariate
and structured data, high-dimensional methods for multi-omics, and integrative analysis of heterogeneous data
types. In summary, the DMA Core will be an integral component for Precision-CARRS by offering essential
data management and analysis support for PPG research aims, while enhancing the reliability, relevance and
reproducility of the PPG’s findings to utlimately sustain the long-term impact and collaborative potential of
Precision-CARRS.